Enhancing Non-communicable diseases Research and Innovation Capacity in Harare, Zimbabwe (ENRICH)

Project Summary/Abstract: The University of Zimbabwe through its Faculty of Medicine and Health
Sciences (UZFMHS) is the lead centre for medical research in Zimbabwe. Currently there is a dearth of
researchers to address priority NCDs in Zimbabwe and sub-Saharan Africa in general. To address this gap
this application will establish the ENRICH program (Enhancing Non-communicable diseases Research and
Innovation Capacity in Harare, Zimbabwe) to train a critical mass of Investigators at the UZFMHS to become
proficient in NCD research. Research training and capacity building will be conducted in Cardiovascular
Diseases, Pulmonary Diseases, Hematology, Stroke and Neurological Diseases, Aging and Dental and
Craniofacial Diseases. The long-term goal is to generate evidence for interventions to improve care for people
with NCDs in Zimbabwe and sub-Saharan Africa. The objectives of the program are to:
1. To train entry level graduate trainees up to post-Doc trainees to undertake high level research on NCDs
in Zimbabwe.
2. Identify high research priority topics across the lifespan in selected NCDs to provide the research scope
for the ENRICH program.
3. To establish mentoring relationships between trainees and dedicated and experienced mentors using
rigorous selection criteria.
4. Strengthen research dissemination and knowledge translation to inform policy and practice.
The ENRICH program will be implemented by UZFMHS faculty assisted by faculty from regional and
international partners i.e. WITS University and University of Colorado Denver respectively. In addition, the
program will collaborate with UZFMHS affiliated research centers such as AiBST, UZ-CRC, UZ-CTRC, BRTI
among others. The research training in the chosen scientific NCD areas have been selected because of the
national and institutional importance/interest and the opportunity to address research deficiencies in those
areas. The program will consist of integrated training framework involving long term degrees (Masters, PhDs,
post-Docs), medium term technical courses and didactic short term courses. These formal training activities
will be supported by mentorship and mentored projects. In addition, trainees will undertake attachments and
electives at the affiliated research entities and UCD. The period of training vary with the level of training i.e.
2 years for Masters and Post-doctorals and 3 and half years for PhDs. The program will recruit 8 PhDs, 8
Masters and 4 post-Docs over a period of 5 years.

Public health relevance
Project Narrative The ENRCH program will be established at the University of Zimbabwe to initiate and intensify research in NCDs through training and mentoring of Masters, PhDs and Post-doctorals majoring in Cardiovascular Diseases, Pulmonary Diseases, Hematology, Stroke and Neurological Diseases, Aging and Dental and Craniofacial Diseases. The long-term goal is to generate evidence for interventions to improve care for people with NCDs in Zimbabwe and sub-Saharan Africa.